Oral Adherence Trajectories Of Disease Modifying Agents And Associated Relapse Rates Among Patients With Multiple Sclerosis

Adherence to Disease Modifying Agents (DMAs) is vital for disease management of Multiple Sclerosis (MS). The
route of administration of DMA is one of the important factors associated with adherence in general and MS in
specific. With the advent of oral DMAs in the last decade, the landscape of DMA treatment has changed
significantly. Oral DMAs offer convenience in administration and offer other benefits over conventional injectable
DMAs. Most of the previous studies assessed annual DMA adherence as a point estimate using medication
possession ratio or proportion of days covered which failed to account for time-related changes in the adherence
patterns over time. The Group-Based Trajectory Modeling (GBTM) classifies individuals into different adherence
trajectory groups based on the prescription-filling pattern over time. Our preliminary analyses involving 2010-
2012 MarketScan revealed that oral fingolimod was associated with higher odds of being a complete adherer
(Odds Ratio (OR): 2.78, 95% Confidence Interval (CI):1.85-4.16) or a slow discontinuer (OR: 2.62, 95% CI: 1.70-
1.05) relative to injectable DMA. In the past decade, several other new oral DMAs were introduced to treat MS,
such as teriflunomide and dimethyl fumarate. These oral DMAs differ in their treatment regimen and may have
consequences with respect to adherence and relapse. However, there is no real-world evidence regarding the
adherence patterns over time and associated relapse rates with oral DMAs in MS. Therefore, the overall goal of
this research is to evaluate adherence trajectories of oral DMAs over time and associated outcomes in MS
patients. The specific aims of this study are: (1) to evaluate DMA adherence trajectory patterns of oral DMAs in
MS; and (2) to evaluate the effect of adherence trajectories on relapse rates in MS. This study tests the following
hypotheses- (i) adherence trajectory patterns differ across different oral DMAs, and (ii) patients with better
adherence trajectories will have lower relapse rates. This retrospective observational study will involve adults
with MS, with incident oral DMA use from the 2016-2018 MarketScan. The oral DMAs will involve three agents,
namely, fingolimod, teriflunomide, and dimethyl fumarate. Relapse will be defined as inpatient hospitalization or
an outpatient visit with a corticosteroid prescription within 30 days. The novel GBTM will involve finite mixture
modeling for approximating adherence trajectories of oral DMA use over a one-year period. The study will adjust
for selection bias within the multivariable context of the Andersen Behavioral Model. Multinomial regression using
Inverse Probability Treatment Weights (IPTW) based on Generalized Boosted Models (GBM) will be used to
evaluate trajectory patterns across different oral DMAs. Poisson regression models with IPTW based on GBM
will be used to evaluate the relapse rates across oral DMAs with variable adherence trajectories. The study
findings will provide valuable real-world evidence regarding adherence trajectories of oral DMAs and associated
outcomes in MS. The study will have significant clinical and policy implications for understanding and improving
medication adherence of oral DMAs to improve the quality of pharmaceutical care for MS patients.

Public health relevance
This will be the first study to evaluate adherence trajectories of oral Disease Modifying Agents (DMAs) over time and associated outcomes in Multiple Sclerosis (MS) patients. These study findings have important implications for informing clinicians and patients regarding treatment decisions to improve health outcomes. The study will have significant clinical and policy implications for understanding and improving medication adherence of oral DMAs to improve the quality of pharmaceutical care for MS patients.